CORE CENTER

The proposed Colorado Chemosensory Core Facility (CCF) will encompass eight principal investigators including scientists with a substantial record of accomplishment in the field of chemical senses as well as investigators with a substantial record of accomplishment in the field of chemical senses as well as investigators with expertise in other areas of neurobiology. The overall goal of the CCCF is to facilitate research in the chemical senses by providing communal resources and by bringing together productive investigators into a supportive, interactive environment. In order to obtain this overall goal, four interrelated specific aims are delineated. 1. Provide a focal point for increased interactions among participating investigators 2. Catalyze new research directions and interactions 3. Enhance the research capabilities and infrastructure supporting the individual laboratories 4. Facilitate entree of promising investigators into the study of chemical senses In order to accomplish these goals, two Core service areas are proposed. Core A (Gene-Targeted/Transgenic Mouse Core; D. Restrepo and L. Sussel, directors) will develop and maintain transgenic/gene-targeted mice. Core B (Cellular Visualization and Analysis Core; Finger, Restrepo and Young, directors) will provide advanced neurohistology, and cellular visualization services through an institutional multi-photon microscope facility. In addition, Core B will develop quantitative approaches for the rigorous analysis of 3-dimensional image data sets. These cores provide services not currently supported or available through the aegis of other grants and will thereby enhance the research capabilities of the participating investigators.